A cluster-randomized controlled trial testing the effectiveness of the Life Enhancing Alcohol-management Program (LEAP) for Housing First residents

PROJECT SUMMARY/ABSTRACT
People experiencing chronic homelessness comprise a small yet high-morbidity, high-cost subset of the
larger homeless population and are disproportionately impacted by alcohol-related harm. Unfortunately,
traditional abstinence-based treatment does not adequately reach or engage this population, and both
firsthand (problems stemming from one’s own alcohol use) and secondhand (problems stemming from others’
alcohol use) alcohol-related harm persists even after housing attainment. There have therefore been calls for
more flexible and client-centered approaches tailored to this population’s needs. Housing First, which entails
the provision of immediate, permanent, low-barrier, nonabstinence-based housing, is a response to this call.
Research has shown that Housing First is associated with decreased alcohol use, alcohol-related harm, and
publicly funded service utilization. Nonetheless, Housing First residents continue to experience both first- and
secondhand alcohol-related harm. Thus, further community-based interventions are necessary. To this end,
a pilot project was conducted in which researchers as well as Housing First residents, staff and management
codeveloped, implemented, and initially evaluated the Life Enhancing Alcohol-management Program (LEAP).
The LEAP entails low-barrier, community-level, house-wide resident programming—including leadership
opportunities, activities, and pathways to recovery. At the 6-month follow up, LEAP participants reported
significantly more engagement in meaningful activities than control participants (p < .001). Moreover, high
levels of LEAP program engagement (>2 activities per month) predicted significant reductions in alcohol use
and alcohol-related harm (ps < .01). To build on these promising findings, we propose a larger, cluster-
randomized controlled trial of LEAP (N=500) as an innovative, community-based, and client-driven adjunct
to Housing First. In the proposed project, 10 Housing First sites will be optimally matched and block
randomized on a rolling basis to either LEAP or services-as-usual control conditions. At LEAP sites, research
staff will work with housing staff and residents to conduct a needs assessment, form a community advisory
board, and develop and implement this community-level intervention. Participants in the LEAP evaluation will
meet criteria for at-risk drinking and will be assessed at baseline, 3-, 6-, and 12-month follow-ups. Analyses
will test LEAP effectiveness in increasing engagement in meaningful activities, decreasing alcohol use,
ameliorating both first- and secondhand alcohol-related harm, and improving quality of life. Engagement in
meaningful activities will also be tested as a mediator of the LEAP effect on alcohol and quality-of-life
outcomes. Finally, we will assess whether LEAP is associated with reduced costs stemming from participants’
use of emergency health-care and criminal justice services.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT We will test the effectiveness of the Life Enhancing Alcohol-management Program (LEAP) in reducing alcohol use and alcohol-related harm among Housing First residents. In the short term, this project is positioned to make a strong, immediate public health impact by reducing alcohol-related harm and improving quality of life in a vulnerable and marginalized population. In the longer term, the LEAP may have a broader impact on public health by introducing an effective, cost-reducing, community-based program that addresses alcohol use and alcohol-related harm for vulnerable people in congregate living settings.